Diversity Supplement to "Biomarkers, mechanisms and modulation of oxidative stress associated risk factors in carcinogenesis"

Project Summary
Cancer is the second most common cause of death in developed nations, where an estimated 70% of cancers
are attributable to “modifiable” risk factors, including obesity, chronic inflammatory diseases, and poor diet, all
of which have been associated with increased oxidative stress. Colorectal cancer (CRC) is the second leading
cause of cancer-related deaths worldwide, with its incidence closely tied to these modifiable factors,
particularly inflammation and metabolic disorders. Of increasing concern is the rise in early-onset CRC
diagnoses in adults younger than 50, who are diagnosed over a decade sooner than the recommended age for
routine screening. Studies have shown individuals who were overweight or obese in childhood are known to be
at a higher risk of developing colorectal cancer (CRC) later in life. The parent grant focuses on determining the
role of oxidative stress in cancer development, specifically targeting CRC influenced by lifestyle factors like
obesity, chronic inflammation, and poor diet. Using advanced techniques such as whole genome sequencing
(WGS) and computational analyses, the study aims to pinpoint mutational signatures associated with oxidative
stress-induced DNA damage and their correlation with cancer-promoting lifestyle factors.
In this diversity supplement, our central hypothesis is that CRC susceptibility in the context of obesity arises
from somatic mutations occurring in functional loci, such as those located in accessible chromatin regions. We
propose to leverage multi-omic profiling and computational tools to probe the relationship between reactive
oxygen species (ROS)-mediated mutational signatures and inflammation-driven cancer risk factors using
datasets from the NIH Common Fund (HuBMAP & GTEx). This supplement aligns with the parent grant's
mission to investigate lifestyle risk factors, oxidative stress, and CRC risk, extending its focus to explore
mutations in open chromatin sites under altered metabolic conditions and studying mutagenesis in colorectal
stem progenitor cells. To elucidate the molecular pathways linking early-life obesity to CRC susceptibility, it is
crucial to model and investigate the effects of hyperglycemic conditions and other mutagens during key
developmental stages. Colonic organoids derived from induced pluripotent stem cells (iPSCs) will provide an
excellent model system for studying CRC development in vitro. By exposing these organoids to mutagenic
agents, we can mimic early-life exposures and assess their impact on mutagenesis and CRC risk. Additionally,
leveraging developmental GTEx data will enable us to map chromatin accessibility across different
developmental staging, allowing us to correlate the timing of mutagenesis and the effect on mutation
accumulation and functional impact. The overarching objective of our study is to comprehend how early-life
obesity and metabolic dysfunction increase susceptibility to mutagenesis leading to CRC development.

Public health relevance
Project Narrative Colorectal cancer is a significant cause of death worldwide and is driven by modifiable risk factors like obesity and metabolic disorders. Our proposal aims to leverage public datasets and colonic organoids to model early- life metabolic exposures to profile genomic mutations in functional loci that may increase CRC susceptibility.